Development of RORgt Immunomodulators Targeting the TH17 Axis in IBD

DESCRIPTION: Th17 cells are a lineage of T helper cells that have recently been identified as critical mediators of the immunopathology of several human inflammatory disease states, including inflammatory bowel disease (IBD). The orphan nuclear receptor RORγt has been shown to be the master controller of the differentiation of Th17 cells. RORγt knockout animals are highly resistant to several autoimmune diseases. In the body the intestine has the highest proportion of Th17 cells compared to other organs. With relevance to IBD, substantially reduced numbers of Th17 cells are found in the intestinal lamina propria of animals with RORγt-null T-cells, compared to wild-type. Antagonism of the transcriptional activity of RORγt results in blocking the differentiation of CD4+ T-cells to the Th17 cell lineage. Thus, RORγt antagonists reduce the Th17 cell population at sites of inflammation. Th17 cells secrete large quantities of IL-17A, IL-17F, IL-22, TNF-α and other inflammatory cytokines. RORγt is important for production of these cytokines and it has been demonstrated that RORγt antagonists reduce the secretion of these cytokines from pre-existing Th17 cells. Therefore, small molecule antagonists of RORγt will be efficacious in modulating the pathogenesis of IBD by reduction of the Th17 cell population and IL-17A/F production. Some small molecule tool compounds have been reported that attenuate autoimmune disease in animal models, but none of these possess sufficient drug-like properties to be considered as viable starting points for drug discovery programs. Using our proprietary RORγt BindingSIGHTs (patent pending) structure-guided drug design platform we have performed an in silico screen of 22 million compounds obtained from our MANIFOLD virtual compound library (the largest in the industry). Subsequently, more than 1000 commercially available drug-like compounds were tested in cell-based luciferase reporter assays for antagonism of RORγt-mediated transcription. Potent hits were further evaluated for selectivity against closely related nuclear receptors. Some compounds were functionally active to inhibit the ex vivo differentiation of human Th17 cells. Based on the success of the preliminary data we propose the following aims: (1) optimize the pharmacological properties of novel RORγt antagonists using our proprietary BindingSIGHTs drug design platform to guide sophisticated medicinal chemistry; (2) determine the ex vivo T-cell functional activity of RORγt antagonists on human Th17, Th1, Th2 and Treg cells; (3) evaluate the therapeutic efficacy of RORγt antagonists in animal models of IBD. Together, these studies will provide highly advanced and novel drug-like chemical matter with the appropriate pharmacological profile to establish the feasibility of our approach. This will ultimately enable subsequent IND-enabling studies and clinical trials.

Public health relevance
Th17 cells are a lineage of T helper cells that have recently been identified as critical mediators of the immunopathology of several human inflammatory disease states, including inflammatory bowel disease (IBD). The orphan nuclear receptor RORγt has been shown to be the master controller of the differentiation of Th17 cells. The goal of the proposed research is to develop potent and novel small molecule RORγt antagonists that are functionally active to inhibit Th7 cell differentiation and are therapeutically effective in animal models of Crohn's Disease and Ulcerative Colitis. The results of these studies will establish proof-of-mechanism that RORγt antagonists can provide therapeutic benefit in IBD.